MUSC/HCC Paul Calabresi Clinical Oncology Career Development Program

PROJECT SUMMARY / ABSTRACT
This application proposes to enhance the Paul Calabresi Clinical & Translational Oncology Training Program at
the Hollings Cancer Center (HCC) of the Medical University of South Carolina (MUSC) – referred to as the
HCC Calabresi K12 Program. The Hollings Cancer Center is the only NCI-designated cancer center in the
State of South Carolina. Development of innovative and impactful clinical and translational research in
hematologic and solid tumor malignancies is the top strategic goal for the HCC. Organized into several strong,
thematic, interdisciplinary research programs, the HCC has made substantial progress towards this goal. This
K12 Program provides the next generation of scientists the opportunity to prepare and expedite the translation
of science into the clinic. With new leadership, the HCC is undergoing strategic expansion, with an emphasis
on the recruitment and advancement of physician-scientists. While a robust pipeline of cancer focused
research training is offered at HCC-MUSC, which spans from high school to undergraduate, graduate and
postdoc training opportunities, the HCC Calabresi K12 Program is the only NCI-funded early career faculty
development program in South Carolina. As the flagship program, it educates and nurtures junior investigators,
called Calabresi Scholars, at the critical juncture prior to transitioning to research independence in a strong
culture of team science among cancer investigators encompassing a broad range of disciplines. The program
builds on the outstanding strengths of the HCC and MUSC including: 1) a robust infrastructure of shared
research resources; 2) a diverse and growing patient population; 3) a NIH funded Clinical and Translational
Science Award (CTSA) program with a Master of Science in Clinical Research (MSCR) option; 4) Program
Faculty Mentors, comprised of basic and physician scientists, who have well-established track records and
funding in collaborative translational research, and 5) a major institutional investment in translational cancer
research. The 40 Program Faculty Mentors identified in this application and the Calabresi Scholars constitute
the core of patient-oriented research at the HCC.

Public health relevance
PROJECT NARRATIVE The Hollings Cancer Center at the Medical University of South Carolina Calabresi K12 Scholars Program reaches across multiple disciplines to develop a cadre of highly trained early career clinician scientists committed to clinical and translational cancer research. Intensive, mentored, interdisciplinary research and career development training helps ensure that there is a diverse pool of independent research- focused scientists equipped to discover and deliver novel therapeutics for effective cancer care.